BUDESONIDE CONTROLLED ILEAL RELEASE CAPSULES IN ACTIVE CROHN'S DISEASE

The purpose of this randomized, placebo controlled, multicenter clinical trial is to investigate the efficacy and safety of budesonide CIR in patients with Crohn's Disease affecting the ileum and/or ascending colon.